Assessing Children's Screen Time with Wearable Sensor

Project summary
The explosion of digital technology ownership in the past decade has led to a dramatically increased screen
exposure for children. In the United States, over 95% of families with children have a smartphone, TV, and
desktop monitors, which has raised a growing concern about the impact of screens on children's health.
Excessive screen exposure has been closely associated with increased eye problems, sleep disorders, obesity,
and cognitive impairments among children. Due to these concerns, World Health Organization (WHO) has
recently (April 2019) suggested that children between 2 and 4 should have less than 1 hour of sedentary screen
time per day. However, there is an evidence gap between actual screen time in research and parental control
and assessment from measurement tools. Existing methodologies of assessing screen exposure lack construct
validity, as they heavily rely upon self-report, smartphone applications, or research technologies (e.g. eye-
tracking glasses). Self-report is prone to reporting bias. Smartphone applications lack the capability of measuring
cumulative, concurrent screen exposure across multiple screen types and are not able to confirm the identity of
user (the same child or his/her parents). Research technologies, such as eye-tracking glasses, can be invasive
to children and are limited to the measurement of regions of selective visual focus. Currently, there is no effective
and minimally invasive tool that can be used to provide objective and accurate measurement of both sedentary
screen use and screen exposure across multiple screen types. This project seeks to develop a wearable device
and robust AI algorithms to provide objective and accurate screen time measurement for children. Aim 1 will
develop a minimally invasive device and computer vision methods to detect screen exposure patterns and
differentiate various screen type. Aim 2 will testify the design in a free-living environment on children. The
proposed work will provide an important new tool to objectively and comprehensively measure children's
cumulative and discrete free-living screen exposure in quantity and duration. We anticipate this technology will
serve as a universal screen-time measurement tool and benefit parents, preschool teachers, and interest groups
in their management and advocacy of child(ren)'s sedentary activities and media use. We also anticipate our
tools will help academic researchers, clinical psychologist, and consumer researchers via providing objective
measures in behavioral study and therapy.

Public health relevance
Project Narrative Children’s screen exposure is closely related to health issues such as increased eye problems, sleep disorders, obesity, and cognitive impairments among children. There is an unmet need to assess children’s daily screen exposure to aid the parental control and academic research on children’s development. This project will develop a wearable device and artificial intelligence (AI) technology to automatically provide accurate measurements of children’s screen exposure on multiple screen device, sedentary activity, and background exposure.